2011 American Pain Society Annual Scientific Meeting

DESCRIPTION (provided by applicant): We are requesting support for travel stipends to encourage the participation of young investigators at the annual meeting of the American Pain Society (APS). These young investigators are beginning their careers in basic and clinical research in pain. The APS is a multidisciplinary community that brings together a diverse group of scientists, clinicians and other professionals to increase the knowledge of pain and transform public policy and clinical practice to reduce pain-related suffering. The annual APS meeting provides a unique forum for disseminating cutting edge advances in evidence-based pain research and treatment in a setting that optimizes the interactions between scientists and clinicians. This bidirectional translational interchange between clinicians who diagnose and manage clinical pain and pre-clinical scientists who are defining the mechanisms of and treatments for pain is the cornerstone of improved pain therapy. We seek funds solely for the purpose of providing travel awards for young investigators who have submitted an abstract which has been accepted by our peer review process and therefore are engaged in research. These young investigators may be from any research training background (basic or clinical science, psychology, medicine, or biostatistics) and may be at any level in training, including students, residents, predoctoral trainees, postdoctoral fellows, or those who have completed their postdoctoral training within the last 3 years. All applicants must be APS members. The APS Young Investigator Travel Awards program is designed to mentor and nurture the next generation of pain researchers. PUBLIC HEALTH RELEVANCE: Pain, both acute and chronic, affects the lives of more that 50 Million Americans and is a major Public Health problem. The annual APS meeting provides a unique forum for disseminating cutting edge advances in evidence based pain research and treatment in a setting that optimizes the interactions between scientists and clinicians. In part through the Young Investigators Travel Award, APS contributes to the training and creative development of the next generation of scientists who will drive pain research and treatment forward. The meeting gives trainees an opportunity to participate in the excitement of cutting-edge research and to interact with senior scientists and clinicians. Ultimately, these interactions will improve the management of pain. Disclaimer: Please note that the following critiques were prepared by the reviewers prior to the Study Section meeting and are provided in an essentially unedited form. While there is opportunity for the reviewers to update or revise their written evaluation, based upon the group's discussion, there is no guarantee that individual critiques have been updated subsequent to the discussion at the meeting. Therefore, the critiques may not fully reflect the final opinions of the individual reviewers at the close of group discussion or the final majority opinion of the group. Thus the Resume and Summary of Discussion is the final word on what the reviewers actually considered critical at the meeting.

Public health relevance
Pain, both acute and chronic, affects the lives of more that 50 Million Americans and is a major Public Health problem. The annual APS meeting provides a unique forum for disseminating cutting edge advances in evidence based pain research and treatment in a setting that optimizes the interactions between scientists and clinicians. In part through the Young Investigators Travel Award, APS contributes to the training and creative development of the next generation of scientists who will drive pain research and treatment forward. The meeting gives trainees an opportunity to participate in the excitement of cutting-edge research and to interact with senior scientists and clinicians. Ultimately, these interactions will improve the management of pain. Disclaimer: Please note that the following critiques were prepared by the reviewers prior to the Study Section meeting and are provided in an essentially unedited form. While there is opportunity for the reviewers to update or revise their written evaluation, based upon the group's discussion, there is no guarantee that individual critiques have been updated subsequent to the discussion at the meeting. Therefore, the critiques may not fully reflect the final opinions of the individual reviewers at the close of group discussion or the final majority opinion of the group. Thus the Resume and Summary of Discussion is the final word on what the reviewers actually considered critical at the meeting.